Support of the Emory National Primate Research Center

Abstract
The overall goal of this supplement is to develop vaccine strategies that induce strong neutralizing antibody
response against HIV using mRNA and modified vaccinia Ankara (MVA) vaccine delivery platforms. To
address the specific goals of the supplement, we will utilize samples obtained from studies conducted in the
Emory Center for HIV/AIDS Vaccine and Cure Research consortium at the Emory National Primate Research
Center. We propose to use the BG505 MD39 SOSIP mRNA as our vaccine strategy to elicit bnAbs. We
hypothesize that BG505 MD39 mRNA delivered intramuscularly as either full length gp160 or truncated gp140
will induce HIV specific neutralizing antibodies with broad neutralization activity in rhesus macaques.
Additionally, we would like to explore the effect of heterologous SIV Gag/Pol mRNA prime and MVA boost on
the CD8 T cell response and evaluate how the route of immunization alters the ability of CD8 T cells to be
boosted by MVA. We propose two specific aims. In Aim 1, we will compare the immunogenicity of MD39 gp160
and gp140 mRNA IM immunization. In Aim 2, we will characterize the immune response induced through
heterologous mRNA prime and MVA boost and determine if the route of immunization effects the CD8 T cell
response elicited by MVA. By completion of these aims we hope to develop improved vaccination strategy
against HIV that can generate both neutralizing antibodies and T cells.

Public health relevance
WHO estimates that there are currently about 33 million humans living with HIV/AIDS and there is a great need to develop a safe and effective HIV vaccine that prevents infection. The main goal of this project is to develop novel vaccine strategies that prevent infection from a heterologous mucosal HIV challenge in non-human primates.